Evolutionary Tradeoffs in Antibiotic Resistance

Antibiotic resistance emerges when a mutation in a bacterium causes a previously inhibitory concentration of a
compound to become survivable. Through the accumulation of mutations conferring varying increases in
resistance, already many easy-to-treat infections have become nearly incurable, and are spreading in part
anthropogenically. The classical model of resistance evolution, that a resistant mutant has a fitness advantage in
the presence of antibiotic use, and so spreads in the population to near-fixation, captures the rise of antibiotic
resistance, but on closer inspection fails to explain several critical features of resistance. First, antibiotic
resistance rarely reaches fixation in clinical populations; more importantly, sensitivity is higher than the
population-genetic models would predict. Second, antibiotic resistance was present, and likely common, in
clinical infections before the human use of antibiotics even began. Third, despite the widespread prevalence of
antibiotic-producing bacteria in the environment, these same bacteria remain surrounded by sensitive
neighbors. For these reasons, we hypothesize that the existing model of resistance evolution is incomplete, and
in particular that there exist evolutionary factors in the environment which have a potentially countervailing
effect on resistance evolution of similar or greater magnitude to the human use of antibiotics. Here, we will
combine evolution experiments in model systems with computational modeling and database mining of
sequence data to study the constraints on the evolution of resistance, focusing on two key areas: the role of spatial
structure in the evolution of resistance, and the role of selfish genetic elements including phages and parasitic
plasmids. Resistance provides an almost ideal model system for the study of microbial evolution; fitness can be
well defined, imposed selective pressures can be readily tuned, and can emerge either spontaneously or by
horizontal gene transfer. We expect to uncover the evolutionary mechanisms behind the emergence, spread, and
limitation of antibiotic resistance.

Public health relevance
Antibiotic resistance in bacteria is a public health crisis. Understanding the evolutionary dynamics that result in the emergence or suppression of resistance will open new avenues of approach to antibiotic resistance. For individual patients with long-term infections it would allow the development of new therapies which consider and potentially exploit the evolutionary possibilities of the pathogen, while on the population scale, understanding which broad dynamics are important for resistance to spread or be contained could enable new public health strategies.